Administrative Core

The Southwest Environmental Health Sciences Center (SWEHSC) Administrative Core (AC) provides the
necessary infrastructure to integrate the leadership, organization, and strategic vision of the SWEHSC. In
providing overarching support, the AC advances the SWEHSC mission to facilitate and implement innovative
research and community engagement aimed at understanding the mechanisms underlying environmental health
(EHS) risks and disease among people living in arid environments by coordinating SWEHSC research, training,
and community engagement efforts. Accordingly, the AC coordinates and integrates Center activities, attracts
new investigators with outstanding EHS capabilities through the Pilot Projects Program, develops the capacity
of EHS researchers through career development opportunities, facilitates interdisciplinary EHS activities, and
promotes cutting-edge research opportunities. The AC also promotes the translation of findings to improve
medical and public health interventions for people in the arid Southwest environment through the Cellular
Imaging, Omics, and Integrated Health Sciences Facility Cores. Likewise, the AC facilitates statewide, national,
and international SWESHC initiatives, coordinates community outreach, and ensures the integration of the
Facility Cores (FCs) and the efforts and activities of the three Research Focus Groups, which center on
environmental exposures experienced by populations residing in the desert Southwest, lung disease resulting
from environmental exposures, and uncovering the mechanisms underlying adaptive responses to
environmental stress. The ultimate goals of the SWEHSC AC are to 1) support new and emerging research
initiatives that align with the Center vision and mission; 2) ensure that FCs provide the cutting-edge technologies
needed by Center members in an efficient and cost-effective manner that fully integrates all Center resources;
3) increase the number and enhance the career development of investigators, particularly new investigators,
studying EHS issues; 4) assist the CEC in public outreach efforts to people in the Southwest to encourage their
participation in EHS research and community-driven projects; and 5) increase the Center’s research grant base.
Broadly, the AC plays an essential role and provides the necessary infrastructure to ensure the success of
SWEHSC.